Systems biology of Ebola virus and Lassa virus determinants of infection outcome

Project Summary / Abstract
Lassa virus and Ebola virus are two of the most devastating human pathogens and infection with both can
lead to severe hemorrhagic fever with case fatality rates in excess of 70%. It is estimated that tens of
thousands of people die from Lassa fever each year. Despite the high case fatality rates of hospitalized Ebola
and Lassa fever patients, it is well established that asymptomatic or mildly symptomatic infections occur in
both Lassa fever and Ebola. We know that virus genetics play key roles in determining disease severity,
however, mechanistic insights are lacking and no systematic studies have been performed to identify virus
correlates of human disease. Similarly, a high proportion of Lassa fever and Ebola survivors develop serious
long-term symptoms associated with their disease, but virus factors that may determine these complications
remain elusive.
The central hypothesis of this project, is that speciﬁc genetic factors in Lassa and Ebola viruses critically
inﬂuence infection outcomes. Working directly with unique Lassa and Ebola patient and survivor cohorts in
West Africa, we will identify Lassa virus and Ebola virus factors that are determinants of human disease. We
will integrate high-throughput ‘omics’ approaches, high-containment experimentation, and computational
modeling to elucidate molecular networks that determine infectious disease severity. Based on these ﬁndings,
we will build predictive models that can be used to determine risk from Lassa virus and Ebola virus infection.
We will achieve these goals by completing three overarching goals. In Speciﬁc Aim 1, we will create and
analyze large-scale genomic data sets of Lassa and Ebola viruses, and genotype of infected patients. We will
perform deep investigations of how the viruses evolve as they transmit from their natural reservoirs to humans
and between humans, and determine how that can aﬀect clinical outcomes. In Speciﬁc Aim 2, we will
functionally characterize, in a high-throughput manner, individual Lassa virus and Ebola virus mutations
hypothesized to inﬂuence infectious outcomes. Finally, in Speciﬁc Aim 3 we will perform experiments in high
containment to determine functional eﬀects of individual mutations in Lassa virus and Ebola virus, and
investigate mechanisms of immune escape and infection. As part of this aim, we will also engineer antibodies
to better target both viruses, which can be used as a starting point for future therapeutics.